MODULAR ANIMAL HOUSING UNITS FOR PRIMATE NURSEY

DESCRIPTION (Provided by applicant): The CRPRC is one of the eight RPRCS supported by the National Center for Research Resources (NCRR) of the National Institutes of Health (NIH). The Center, provides specialized research facilities, non-human primate (NHP) resources, scientific and professional staff, equipment and technical expertise to support primate related research. This application seeks to purchase two modular animal buildings and primate nursery caging to expand the capacity to conduct research using the infant rhesus macaque. In addition, these two buildings will be equipped with high efficiency particulate air (HEPA) and activated charcoal filters to permit necessary expansion of the infant asthma research program.